The genetics of functional decline in the aging vestibular system: A GWAS and gene expression analysis in aging mice and humans

Fall-related injury in the elderly carries a 20% mortality rate, and is the sixth leading cause
of death in this population. Age-related dysfunction of gravity receptors within the vestibular
system is highly correlated with these elderly falls, and significant age-related degeneration is
associated with nearly all types of vestibular cells. The overarching goal of this study is to analyze
human and mice genome-wide association studies (GWAS), vestibular-specific human and mice
genomic expression, and single-cell sequencing of specific sites in the vestibular system, then
test identified genes and related pathways in the lab. Our objective is to characterize the genomics
related to age-related imbalance for future prevention and treatment. The central hypothesis is
that by this analysis, we can identify anatomic and physiologic sites relevant to the balance system
that is common to both species. Our rationale is that by this analysis, we can better focus on
relevant genes and pathways for lab testing and ultimate therapeutic intervention. Building upon
a small GWAS on elderly falls that correlated human DCC and PTK2 genes in the same pathway
as Dcc identified in the Hybrid Mouse Diversity Panel (HMDP) GWAS, our specific aims will be:
1) a. Perform GWAS in humans based on a dizziness/falls phenotype in a meta-analysis of large
datasets; b. GWAS in mice based on a behavioral and gravity sensor function phenotype in the
HMDP; 2) a. Perform RNA-Sequencing on vestibular tissues from mice and human surgical
specimens; b. Single-cell RNA-Seq on individual tissues; c. Compare identified genes and
pathways via computational methods to assess translation of pathways from the mouse to human
balance system; and 3) Perform functional testing for the top candidates defined in Aim 2 using
knock-out/knock-in mice. Multiple innovations of this project include: 1) the first GWAS of gravity
receptor function in aged mice and in elderly humans, 2) a comprehensive catalogue of genes
and pathways involved in vestibular functional variation with inter-species comparison, as part of
FAIR (findable, accessible, interoperable, reusable) Compliance, 3) in vivo validation in mouse
models and an analysis of these candidates in available human cohorts, and 4) future potential
for targeted therapies. Our outcome is the first comparative GWAS of the balance system
between animal models and humans. The impact of this work will be to lay a firm foundation for
development of targeted treatment of the balance system to diminish falls in the elderly.

Public health relevance
PROJECT LAY NARRATIVE The incidence of dizziness increases from 22% for adults between the ages of 65 and 69 to over 40% between the ages of 80 and 84 years, and fall-related injuries are highly correlated with reports of dizziness, constituting the sixth leading cause of death in the elderly and associated with a 20% mortality rate. We will identify the genes and pathways involved in the vestibular portion of the balance system of humans and aged mice, compare the genomic composition of human and mouse vestibular tissues, then test the hypothesis that the genes and/or pathways identified are critical to balance function. Our team will combine resources with the expertise of a neurotologist, otolaryngologist/data scientist, computational biologists, and neurogeneticists to identify genes and pathways underlying imbalance, leading to targeted therapies for prevention and treatment of imbalance and falls in the elderly.